Neurocognitive implications of cannabidiol (CBD) while aging with HIV

PROJECT SUMMARY
The success of combined antiretroviral therapy (cART) has drastically improved the life expectancy of people
living with HIV. This has resulted in the clinical observations of significant age-related neurocognitive
complications among the population aging with HIV. HIV-associated inflammation has been implicated in
premature aging and increased risk of age-associated comorbidities even in cART-treated individuals. Currently,
people living with HIV are using cannabis, for recreational or medical purposes, at higher rates than the general
population. However, cannabinoids in the context of HIV and aging remain preclinically unexplored. As the use
of medical cannabis among older HIV individuals continues to rise, there is an urgent need to investigate the
consequences of cannabinoids during aging with HIV. The goal of this proposal is to unravel the beneficial versus
the detrimental effects of cannabinoids on HIV and HIV-induced neurocognitive deficits in aged mice. It has been
shown that cannabidiol (CBD) improves both spatial and recognition memory and decreases anxiety in a mouse
model of Alzheimer’s disease, suggesting its therapeutic potential for age‐related dementia. Therefore, we
hypothesize that exposure to CBD will modulate neuroinflammation and cognitive deficits in mice that aged with
HIV. To test this hypothesis, C57BL/6J male and female adult mice (at 16-months old) will be infected with the
mouse-tropic HIV, EcoHIV. After 8 weeks (at 18-months old), a subset of EcoHIV-infected mice will be exposed
to CBD alone, antiretrovirals alone, and concomitant CBD and antiretrovirals for 21 days. In Specific Aim 1, we
posit that CBD will modulate HIV- and age-associated cognitive deficits, specifically memory, and learning
functions, measured by the novel object recognition test and the Y-maze behavioral test. In Specific Aim 2, we
posit that CBD exposure will modulate neuroinflammation, glial phenotypes, and cellular senescence in
postmortem brain tissue of EcoHIV-infected and aged mice recovered in Specific Aim 1. The experiments
described in this proposal will allow us to determine the molecular mechanisms that could mediate the
consequences of cannabinoids exposure in the HIV-infected aged brain. The ultimate goal of this project is
to identify a potential therapeutic target that could reduce age-related neurodegenerative deficits
associated with chronic HIV infection.

Public health relevance
PROJECT NARRATIVE People aging with HIV have above average rates of neurological deficits. With the increased use of cannabis among HIV older patients, there is an urgent need to determine the effects of cannabinoids in HIV-associated neurocognitive complications. The goal of this proposal is to identify the effects of cannabidiol (CBD) on neuroinflammation and cognitive deficits related to HIV in the aged brain using in vivo and ex vivo methodologies.